Understanding Real-World Outcomes of Endovascular Treatment of Claudication

PROJECT SUMMARY/ABSTRACT
Peripheral arterial disease (PAD), defined as narrowed blood vessels causing decreased blood flow to the
extremities, is a common diagnosis, affecting nearly 1 in 5 Americans and costing more than $21 billion
annually. Claudication (pain with walking) is the most common manifestation of PAD. The invasive treatment of
PAD has risen rapidly despite a lack of evidence of the long-term effectiveness of these procedures. Without a
full understanding of the long-term effectiveness of these treatments and the motivations of providers
prescribing these treatments, decision-making remains unclear. Providing long-term data of the effectiveness
of treatment strategies and why providers choose treatments will directly improve patient shared decision-
making.
The goal of this research proposal is to describe the long-term effectiveness of interventions for claudication
and to explore the provider motivations for treatment decisions. The three aims of this proposal are: 1)
Describe the long-term comparative effectiveness of interventions in the treatment of claudication, 2) Measure
the heterogeneity of treatment effects of interventions for claudication, and 3) Identify the key motivators of
physician practice by assessing provider perceptions of the effectiveness of medical therapy, open surgery and
endovascular interventions. The first two aims will use novel clinically-rich data from the Veterans Health
Administration to measure the comparative effectiveness of treatment strategies. The third aim will employ
semi-structured interviews to explore provider perceptions of treatment effectiveness and motivations for
treatment decisions. The proposed research and training will provide Dr. Osborne with the necessary skills to
become a leader in comparative effectiveness research in cardiovascular disease and enhance shared
decision-making.
Dr. Osborne's career development will be fostered by the mentorship of a diverse interdisciplinary team.
Training will include graduate level advanced didactic coursework in organizational management, behavior and
theory, qualitative research methods and implementation science. He will acquire new skills in the preparation
of manuscripts, and grantsmanship. This training will directly lead to his development into an independent
investigator, aimed at improving the quality of care for patients with PAD. This career development award will
provide the groundwork for further studies to develop strategies to decrease variation in care and improve the
treatment of patients with PAD.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Project Narrative: Claudication, pain with walking, is a common form of cardiovascular disease that can be treated medically or with procedures. Despite a lack of evidence, catheter-based procedures to increase blood flow are increasingly common. Using a combination of complex statistics and qualitative methods, this study seeks to measure the long-term effectiveness of these procedures and explore why providers choose different treatment options.